Advancing drug discovery for protein domains containing intrinsically disordered regions

PROJECT SUMMARY (ABSTRACT)
In the past, protein function was viewed as dependent on a well-defined, folded three-dimensional structure;
now, it is well established that disordered regions actively participate in the diverse functions mediated by
proteins. Intrinsically disordered regions (IDRs) are abundant in the human proteome and these IDRs cultivate
dynamic, transient interactions. The process of transcription is regulated by dynamic, IDR-containing proteins.
Such proteins are overrepresented in multiple major disease pathways, making them ideal targets for drug
discovery. Transcriptional coactivators are central proteins in transcriptional regulation; however, traditional
drug discovery methods are less effective for targeting these dynamic domains, so there is a need for a
directed approach to target these structures. IDRs evoke the conformational malleability of transcriptional
protein domains in their essential protein-protein interactions (PPIs), thus conformational stabilization can be
utilized as a modulation marker for dynamic domains. My research focuses on building a novel system to
identify modulators of the dynamic transcriptional coactivator domains, KIX and HEAT and optimize modulators
for use in therapeutics. Dysregulation of protein-protein interactions (PPIs) between these domains and their
partnering transcription factors (TF) promotes several TF-dependent cancers. Representing the two major
types of IDRs, the IDR within KIX acts as an allosteric site and the one in HEAT is an orthosteric site. My first
aim is the identification of a variety of IDR modulators that functionally invoke conformational stabilization of
these IDR-containing domains. There is a high correlation between conformational stability and thermostability;
thus, for KIX primary screening, high-throughput differential scanning fluorimetry (HT-DSF) has been employed
to observe IDR modulation by measuring change in protein thermostability upon ligand binding. With the
preliminary KIX hits, follow-up fluorescence polarization (FP) screening will identify the hits that modulate the
IDR in KIX such that its native PPIs are enhanced or inhibited. An expression and purification procedure will be
developed to produce a stable HEAT construct. This domain will then be subjected to a HT-DSF and follow-up
FP to define molecules that alter its IDR and native PPI binding. My second aim is the optimization of IDR
modulators to be defined as therapeutic candidates. Collaborative structural assessment will then connect IDR
modulation to modulation site, establishing structural models and defining ligand binding classes. Using the
structural models, concerted high-throughput lead optimization will be performed for each ligand class to
enhance their therapeutic potential. By implementing this system for the KIX and HEAT domains, it will be
considered applicable for targeting an array of ‘undruggable’ dynamic domains and advancing the drug
discovery efforts for this class of proteins.

Public health relevance
PROJECT NARRATIVE Disorder-containing protein domains inherently have a dynamic nature and play important roles in numerous physiological processes as well as pathological states. In this work, I propose an innovative workflow for the high-throughput identification and optimization of modulators for two distinct, dynamic transcriptional coactivator domains, KIX and HEAT, the results of which will directly contribute the cancer therapeutics. This workflow will be pivotal for the successful targeting of conformationally dynamic proteins, a class of proteins that is known to contribute to numerous diseases but is largely considered to be ‘undruggable’.